Opioid effects on cognition and addiction: Molecular underpinnings

Project Summary
Opioid overdoses kill more than 130 Americans every day, yielding over 47,500 deaths per year, and the same
number of deaths in the 9/11 attacks every 23 days. The best treatments for opioid use disorder (OUD) are
medication-assisted therapies such as methadone, buprenorphine, or naltrexone, and are inadequate to buttress
the epidemic. Failure to treat OUD is sourced in not understanding the molecular pathophysiology of OUD,
including its clinical manifestations as a biological, psychological, and behavioral disease, the neurobiological
mechanisms that reinforce its consumption, and how repeated consumption affects other neurocognitive
processes. The Hurd lab recently discovered a genomic locus associated with OUD, downstream of the protein
tyrosine-kinase FYN, in striatal neurons from human heroin abusers. Additionally, heroin increased Fyn
expression in the striatum of rats that undergo heroin self-administration (SA), and in primary striatal neuronal
cultures. FYN phosphorylates tau, and hyperphosphorylation of tau is known to precede neurofibrillary tangles,
a hallmark of neurocognitive disease. This proposal leverages high-throughput electronic medical records (EMR)
from the Mount Sinai Health System to examine how chronic opioid exposure affects the odds of neurocognitive
disease (NCD) on a population level, and EMR from two other hospitals at Columbia University and the University
of San Francisco to replicate these effects, using the same analysis pipeline. Additionally, I propose mechanistic
studies of Fyn overexpression in the orbitofrontal cortex (OFC), a region known to be affected in NCD and OUD,
on heroin SA and cognitive behaviors using animal models. Further, I used a machine learning approach with
RNA-seq data obtained from human post-mortem OFC tissue to classify subjects as either belonging to the
heroin overdose or control group based on the expression of ~10 genes. Three feature (gene) importance metrics
highlighted a transcript, SHISA7, that was reduced in the human OFC, and this finding was replicated in the OFC
of rats that underwent heroin self-administration. SHISA7 and FYN both regulate the synaptic function of AMPA
receptors, and are components of the post-synaptic density of glutamatergic neurons. I will examine the impact
of overexpressing SHISA7, identified using this machine learning approach, in the OFC on heroin SA and
cognitive behaviors in animal models. Finally, I will conduct RNA-sequencing experiments on the OFC from Fyn-
and Shisa7-manipulated animals, and in downstream bioinformatics analyses, parse key drivers of gene
networks to identify potential mechanisms that account for the contribution of these genes to heroin SA and
cognitive behaviors. High-throughput clinical and gene expression data from the human can inform translational,
mechanistic studies using animal models that will enable a far-reaching understanding of the molecular
disturbances underlying the effects of opioids on cognition and addiction.

Public health relevance
Project Narrative The opioid epidemic is killing over 130 Americans every day, and current treatments consist of opioid substitution therapies, which are fraught with challenges and ineffective at slowing the epidemic. Opioid use disorder is a biological, psychological, and behavioral disease, and our scientific understanding of it must proceed along multiple dimensions of analysis to elucidate its underlying molecular pathophysiology, with the end goal of formulating novel treatments. This project will gain insights into the molecular underpinnings of how opioids affect cognition and addiction, starting from high-throughput human studies using advanced computational methods, proceeding to mechanistic studies using animal models of reversal learning and heroin self-administration behaviors, and further through deep sequencing and bioinformatics studies to characterize gene networks and key drivers impacted by opioid exposure.